Single Cell Analysis Core

SUMMARY
A central goal of this P01 program project is the comprehensive interrogation of how cellular senescence affects
the gene expression, phenotype, and function of diverse cell populations in various tissues following infection or
vaccination. As traditional single-cell omics omits critical phenotypic and spatial information, the Single-Cell
Analysis core will provide with innovative approaches to accurately identify immune cell populations and their
functionality in their spatial context. This will be achieved by providing a consistent and validated pipeline of
multiple high-throughput omics approaches including, single-cell RNA sequencing, cellular indexing of
transcriptomes and epitopes by sequencing, cytometry by time of flight, spatial transcriptomics, and mass
imaging. Interpretation of these data and their integration between the individual Projects will require a consistent
experimental design and sample acquisition, as well as a significant effort of bioinformaticians with expertise in
the biology of aging, immunology, and single-cell analysis. The Specific Aims of the Single-cell Analysis Core
are: 1) Provide a quality-controlled platform and custom reagents for the single-cell and spatial genomics
assessment of senescent cells; 2) Provide bioinformatics and statistical analyses of single-cell and spatial omics
datasets; and 3) Develop a database to warehouse, integrate, and share datasets.